Development of drug conjugates of R-spondin peptibodies for the treatment of colorectal cancer

PROJECT SUMMARY
Colorectal cancer is still a major cause of cancer-related death in the world and only a small subset of
patients benefits from therapy by immune checkpoint inhibitors. Antibody–drug conjugates (ADCs) are
monoclonal antibodies (mAbs) that are covalently linked to cell-killing drugs and have emerged as a
major modality in anti-cancer treatment. This approach combines high specificity of mAbs against their
antigen targets with highly potent cytotoxic drugs, resulting in “armed” mAbs that deliver the payload
(drug) to tumor cells with enriched levels of the antibody target. The approach has become a major
modality of cancer therapeutics with several ADCs approved in the last few years. Leucine-rich repeat
containing, G protein-coupled receptor 4, 5 and 6 (LGR4-6) are three related receptors that are highly
upregulated in colorectal cancers. They bind R-spondins (RSPOs), a group of secreted proteins with
high affinity and potentiate Wnt signaling. Aberrant RSPO-LGR signaling plays critical roles in tumor
formation, progression, and drug resistance. In particular, LGR5 is enriched in cancer stem cells of
colon cancer and LGR5-positive cells drive tumor growth and metastasis. However, LGR5-positive and
-negative cells can interconvert and ADCs targeting LGR5 inhibited tumor growth but failed to
completely eradicate tumors due to cancer cell plasticity. Remarkably, LGR5-negative cells still
express LGR4 or LGR6 or both. We reasoned that simultaneous targeting LGR4-6 may overcome
cancer cell plasticity and drug resistance. Recently, we demonstrated that a mutated form of RSPO
can bind to LGR4-6 with high affinity without potentiating Wnt signaling. Drug conjugates of RSPO
mutant fused to IgG1-Fc domain was able to inhibit tumor cell growth in vitro and in vivo. We have
now generated a pyrrolobenzodiazepine dimer (PBD)-based drug conjugate of an RSPO2 mutant that
showed potent anti-tumor effect in colon cancer models in vitro and in vivo. In this proposal we will
evaluate the drug conjugate in a series of colon cancer models in vitro and in vivo and determine its
tolerability in mice. These results and conclusions may, for the first time, validate PBD-conjugated
RSPO-Fc protein as a novel approach for simultaneous targeting of LGR4-6 for colorectal cancer
treatment and identify drug candidates for further development.

Public health relevance
Public Health Relevance Statement: Project title: Development of drug conjugates of R-spondin peptibodies for the treatment of colorectal cancer. Contact P.I. Jie Cui Statement: Colorectal cancer remains a major cause of cancer-related death in the world. The proposed study aims to establish proof-of-principle in preclinical models for the use of drug conjugates of R-spondin peptibodies against a group of related receptors that are highly upregulated in colorectal cancer. The work may lead to the discovery and development of a novel class of therapeutics for the treatment of colorectal cancer patients.